Controllable solid tumor immunotherapy based on a wireless thermos-activator

Abstract
Chimeric Antigen Receptor (CAR) T cell therapy is a groundbreaking treatment for cancer, with the potential to
elicit long-lasting immune responses. However, its application in solid tumors is significantly limited by off-tumor
toxicities, where normal tissues expressing similar antigens are targeted, leading to lethal side effects (on-target
off-tumor toxicity, OTOT). Therefore, there is an urgent need for high-precision control of CAR T cells to confine
their activation to local tumor regions. We previously demonstrated the feasibility and safety of using MRI-guided
focused ultrasound to precisely control CAR-T cell activation through local hyperthermia. Despite its potential,
this approach has notable limitations, including restricted accessibility due to the need for specialized MRI
equipment. To overcome these barriers, this project proposes the development of a wearable patch controlled,
wireless thermo-activator device that enables precise, localized CAR-T cell activation at tumor sites through
controlled heat. The system includes injectable, biodegradable receiver micro-coils, a wearable of a flexible Tx
coil and a flexible metasurface. This innovative approach offers remote thermal control, activating thermo-
activator CAR-T (TA-CAR) cells with high spatiotemporal precision, providing a convenient, portable, patient-
friendly alternative to MRIgFUS. Accordingly, three specific aims are proposed: (1) to develop and optimize
wireless injectable thermo-activator device, (2) to test wireless thermo-activator on engineered CAR-T cells for
tumor cell killing in vitro, and (3) to evaluate the in vivo therapeutic efficacy of the wireless thermo-activator
controllable CAR T cells in solid tumor killing. By providing a flexible, accessible, and repeatable method for
CAR-T activation, this technology seeks to enhance the safety and efficacy of cancer immunotherapy. We expect
that each component of our approach, wearable controlled thermos-activators, thermo-controllable CARs, will
allow opportunities for continuous evolution and adaptation, targeting a broad range of solid tumors and
precancerous conditions. This wearable patch controlled therapy offers a groundbreaking advancement in
remote-controlled immunotherapy against solid tumors, holding promise in translations to clinical applications.

Public health relevance
Project Narrative This project aims to develop a wearable patch controlled wireless thermo-activator to precisely activate CAR-T cells locally at tumor sites, offering a safer and more effective treatment for solid tumors. By optimizing the wearable patch controlled wireless thermo-activator and improving the control and targeting of these immune cells, this technology has the potential to reduce harmful side effects and increase the success rate of immunotherapies. In the long term, this research could lead to more accessible, remote controllable, and personalized treatments, ultimately enhancing health outcomes and improving the quality of life for patients.